Multi-racial genetic analysis of hidradenitis suppurativa

Project summary
Hidradenitis suppurativa (HS) is an underrecognized common, immune-mediated skin disease
characterized by inflammatory nodules, abscesses, and sinus tracts in the groin, buttocks, and axillae
leading to devasting physical and emotional morbidity. HS significantly affects European Americans and
minorities such as African-Americans, Asians, and Latinos. Treatments for HS are poor, with only a
single FDA-approved therapy available. The paucity of treatments is driven by a profound lack of
understanding of HS pathogenesis, particularly with respect to the genetic pathways involved. In this
application, we utilize a variety of innovative approaches to address this significant gap. First, we perform
a genome-wide association study (GWAS) in European, African American, and Asian HS cases and
healthy controls. Second, we perform trans-ethnic genome wide meta-analysis to identify shared and
distinct genetic risk factors. Third, we will perform multi-racial spatial transcriptomics and proteomics of
HS skin to elucidate cell-cell interactions, and further identify causal GWAS variants through luciferase
reporter assays. Together, these studies will advance our knowledge of the genetic architecture and
immunobiology of HS in different racial populations and identify new biologic pathways that can be
therapeutically targeted.

Public health relevance
Project narrative Hidradenitis suppurativa (HS) is a debilitating, inflammatory skin disease with few effective therapies. There has been a lack of well-powered genetic studies of HS. In this proposal, we use large genetic datasets, novel bioinformatics methods, and cutting-edge functional assays to identify and characterize HS genetic variants, which may lead to the identification of new therapeutic pathways in HS.